FETOSCOPIC NEUDYMIUM--YAG LASER / TWIN TWIN TRANSFUSION SYNDROME

Monochorial placentation threatens twin and higher multiple pregnancies by shunting blood from one fetus to the other. By interrupting the common vessels with a fetoscopically delivered neudymium: YAG laser the investigator hopes to improve the survival and decrease morbidity of the fetuses.